Genetic Architecture of Parkinson's Disease in African-American and Latino Veterans

Parkinson’s disease (PD) is the fastest growing neurological disorder and its worldwide prevalence is expected
to double by the year 2040, a trend that some have labeled the “PD pandemic.” Disease disease-modifying
therapies and better methods of detection in early or pre-symptomatic phases are desperately needed and
data from human genetic studies have moved us much closer to those goals. Unfortunately, such studies have
largely excluded individuals of non-European origin which risks further worsening existing health disparities for
minority populations. The project seeks to address this gap in knowledge by studying the genetic architecture
of PD in African American and Latino participants in the Million Veteran Program (MVP) and other cohorts.
The research team assembled for this project has extensive expertise in clinical movement disorders,
bioinformatics, molecular genetics, and statistical genetics with specialized knowledge in mapping disease
genes in “admixed” (mixed ancestry) populations. This same group of investigators recently published the first
and only admixture mapping analysis and genome-wide association study (GWAS) of PD ever conducted in a
Latino population (based on a cohort from the Latin American Research Consortium on the Genetics of
Parkinson’s Disease [LARGE-PD]).
The fundamental approach will be to perform two complementary techniques (1) admixture mapping, a
technique that leverages local ancestry to identify regions of the genome where ancestry from a particular
ancestral population is inherited more frequently in cases vs controls, and (2) Tractor GWAS, a new analytical
approach that unlike traditional GWAS methods is designed to accommodate admixed individuals. A Discovery
sample will be created using cohorts from MVP and the Veterans Parkinson’s Disease Genetics Initiative (Vet-
PD) and a Replication sample will be assembled from LARGE-PD and several publicly available datasets.
Admixture mapping and Tractor GWAS will first be performed on the Discovery Sample, analyzing each
ancestry group separately and all groups combined. We will also perform the “variant-set test for association
using annotation information” (STAAR) to perform gene-centric association tests of rare variants that are not
suitable for single-marker analyses (such as GWAS). These processes will be repeated in the Replication
sample to validate results. Prioritization of candidate regions discovered will be performed using a combination
of (1) physical position on the genome (positional mapping), (2) expression quantitative trait locus (eQTL)
mapping, and (3) chromatin interaction mapping.
In addition, polygenic risk scores (PRS) will be calculated. A PRS is an estimate of an individual’s genetic
liability to a trait or disease, calculated according to their genotype profile and relevant GWAS data. These
scores have been applied to an increasing number of diseases with the eventual goal of risk stratification
followed by clinical interventions. But PRS models based on GWAS results from individuals of European origin
are often less accurate when applied to non-European populations. Therefore, PRS models will be
constructed from the European, African, and Latino components of the Discovery sample and their
performance will be compared across all three subgroups (e.g., Latino to African American and Latino to
European American). Finally, findings from this project will be cross-validated with results from any other
suitable studies that become available in future years.
Results from this project will provide a better understanding of the genetic architecture of PD in African
Americans and Latinos which is important for two reasons. First it moves the field closer to a more equitable
balance in the application of genetic information to clinical decisions in future years (e.g., PRS models).
Second, it begins to unlock the potential for new PD gene discovery in non-European populations which will
further our understanding of PD pathophysiology.

Public health relevance
Parkinson’s disease (PD) is the fastest growing disorder of the nervous system and affects about 110,000 Veterans. Genetic studies have provided vast quantities of data that will be used to better diagnose and treat PD, but most of them have been done in people of European ancestry. The problem is that some of the results cannot be generalized to people of other ancestries who might not be able to benefit as much from the advances in treatment this information will provide. This project will address that disparity by examining the genetics of PD in African American and Latino Veterans in the Million Veteran Program (MVP) and the Veterans Parkinson’s Disease Genetics Initiative (Vet-PD). We suspect that some genes have a larger influence on the risk of developing PD in these two groups than in people of European origin. Finding these genes will provide researchers with even more opportunities to learn about the causes of PD and ultimately allow clinicians to make better decisions about treatment based on a person’s genetic profile.